The multifaceted roles of PI(4,5)P2 on HIV-1 assembly

PROJECT SUMMARY/ABSTRACT
The HIV/AIDS pandemic has claimed more than 43 million lives worldwide. While effective antiretroviral therapies
are widely available, poor adherence and the emergence of resistance remains a pressing challenge. Despite
the notable advance in HIV-1 treatment over the decades, continuing basic research remains critically important
to address the challenges posed by this rapidly evolving virus. HIV-1 assembly relies heavily on
phosphatidylinositol (4,5)-bisphosphate [PI(4,5)P2], a lipid that recruits the viral Gag protein to the plasma
membrane (PM), where Gag orchestrates the assembly process. Intriguingly, our recent research suggests that
PI(4,5)P2 has additional roles in HIV-1 assembly beyond simply recruiting Gag to the PM, indicating multiple,
yet-undefined functions for this lipid in the viral life cycle. In the Aim 1 of this proposal, I will focus on elucidating
the interplay between Gag multimerization and PI(4,5)P2 enrichment at HIV-1 assembly sites at the PM. I will
also determine how this interplay facilitates the sorting of cellular proteins that either enhance or inhibit HIV-1
spread. Despite significant advances, the molecular mechanisms driving the incorporation of the HIV-1
glycoprotein Env into viral particles remain incompletely understood. In Aim 2, I will investigate the role played
by PI(4,5)P2 in recruitment and incorporation of HIV-1 Env across various cell lines and primary CD4+ T cells.
For this aim, I will use an innovative method for PI(4,5)P2 inhibition to probe this mechanism. Finally, our recent
study raised the possibility that rather than promoting PI(4,5)P2 clustering, Gag can also be targeted to pre-
existing PI(4,5)P2 pool at the PM. In Aim 3, during my independent research phase (R00), I will focus on
elucidating whether Gag is addressed to pre-formed PI(4,5)P2 pools at the PM. In addition, I will elucidate the
role of membrane contact sites (MCSs) in HIV-1 protein trafficking and assembly. MCSs, which facilitate direct
communication between cellular organelles, have recently emerged as key players in non-canonical pathways
for the targeted delivery of proteins and lipids. Interestingly, certain protein complexes that regulate ER-PM MCSs
are known to enrich PI(4,5)P2, a lipid critical for HIV-1 assembly. Therefore, ER-PM MCSs may be a key
mechanism for Gag trafficking to the PM, bypassing the canonical secretory pathway. By investigating these
processes, my work will address significant gaps in our understanding of HIV-1 assembly that can push the field.
Beyond research, I will engage in career development activities including technical training, leadership and
diversity workshops, and regular advisory committee meetings to discuss progress and receive guidance to my
transition to independence.

Public health relevance
PROJECT NARRATIVE Despite significant advances in treatment and care, HIV continues to pose a global health threat. This research will deepen our understanding of both viral and host factors that drive HIV-1 replication, with a particular focus on the crucial role of phosphatidylinositol (4,5)-bisphosphate [PI(4,5)P2] in HIV-1 assembly. Ultimately, this work will also explore the potential of PI(4,5)P2 inhibitors in preventing HIV-1 spread, contributing to global efforts aimed at ending the HIV/AIDS pandemic.